Cortical encoding of unconscious visual information and its impact on behavior

PROJECT SUMMARY/ABSTRACT
Stimuli presented too briefly to be noticed can nonetheless facilitate the perceptual processing of the same
stimuli many minutes later. Whereas the phenomenon of subliminal priming has been known for decades,
whether and how sensory information is encoded in the brain in the absence of awareness in a way that
influences subsequent sensory processing across neuronal circuits remains a mystery. We will answer these
questions for the first time by examining, at single cell resolution, whether exposure to subliminal stimuli
influences perceptual performance and the coding of information across visual cortical populations. To
accomplish this goal, we will use multiple-electrode recording of single-unit activity in macaque early and mid-
level visual cortical areas (V1 and V4) and behavioral techniques to examine the dynamics and coding in
neuronal populations during and after subliminal exposure, and their impact on perceptual performance. Aim 1
will investigate whether exposure to subliminal stimuli increases subsequent perceptual performance and the
amount of information encoded in population activity. Our hypothesis is that subliminal exposure improves
perceptual discrimination performance when stimuli are subsequently presented above the detectability
threshold, and increases the amount of information extracted from the population response. Aim 2 will examine
the mechanism of the improvement in neuronal and behavioral performance after subliminal exposure. We will
first focus on causal experiments involving optogenetic inactivation which will test whether suppressing
neuronal activity in visual cortex during the presentation of subliminal stimuli reduces the strength of subliminal
priming. Cross-correlation analysis will subsequently test whether improved network and perceptual
performance after subliminal exposure is consistent with a Hebbian mechanism underlying the increase in
functional connectivity specifically for the neurons activated by subthreshold stimuli. Aim 3 will examine the
impact of attention on the relationship between subliminal priming and neuronal and perceptual performance.
We will test the novel hypothesis that spatial attention reduces the efficacy of subliminal priming – exposure to
unattended subliminal stimulation will be associated with a larger improvement in network coding and
perceptual performance compared to exposure to attended information. In contrast, we expect that attention
will increase the strength of supraliminal priming, i.e., exposure to attended subliminal stimulation will be
associated with a larger improvement in network coding and perceptual performance compared to exposure to
unattended information. Taken together, our proposed experiments can potentially advance our understanding
of information coding in visual cortex by testing the limits of sensory experience and its relationship with
perception, which will help develop effective therapies to treat the brain-based aspects of low vision conditions,
such as amblyopia, age-related macular degeneration, diabetic retinopathy, or stroke.

Public health relevance
PROJECT NARRATIVE Although the phenomenon of subliminal priming has been known for decades, whether and how sensory information is encoded in the brain in the absence of awareness remains a mystery. We will perform multiple- electrode recording simultaneously in two visual cortical areas of non-human primate to examine the neural dynamics and coding of subliminal stimuli across neuronal circuits, and their impact on perceptual performance. Our research has the potential to advance our understanding of the neural underpinnings of vision while providing effective non-invasive therapies to treat the brain-based aspects of low vision conditions which can lead to life- altering benefits for many millions of people worldwide.